VIRTUAL TOOLS FOR CARDIAC VENTRICULAR REMODELING SURGERY

7. Project Summary/Abstract There are currently 5 million Americans with diagnosed heart failure (HF), and 550,000 new cases every year. The majority of HF cases is now the result of myocardial infarction (MI)-induced left ventricular (LV) remodeling. The lack of a well-established effective treatment has lead to a continually expanding list of medical and surgical options for the palliation of HF patients. Using our Myocardial Material Property Software Tool (MMPST; developed and validated during the initial funding period) and an ovine model of MI, we have provided cardiologists and cardiac surgeons with new insights into the mechanism of MI-induced HF by focusing their attention on changes that occur in the normally perfused myocardium immediately adjacent to the MI (the borderzone). Our MMPST demonstrates that borderzone (BZ) myocardial contractility is substantially reduced in comparison to that in LV regions remote from the MI. The overall goals of the proposed research are to validate clinical application of our MMPST and demonstrate a strong clinical correlation between regional myocardial contractility and disease state. There are five specific aims: (1) Using our MMPST, measure in-vivo regional myocardial contractility in patients before heart transplantation; (2) Measure ex-vivo regional myocardial contractility in skinned fiber preparation obtained from the hearts studied in Aim #1. We will use these direct active force measurements to validate clinical application of our MMPST; (3) Using diffusion MRI (dMRI), measure ex-vivo regional myofiber orientation in the hearts studied in Aim #1, as well as in normal human hearts and human hearts with an MI. If these clinically relevant measurements are not significantly different (as we previously discovered in normal versus infarcted sheep hearts), then clinical application of our MMPST does not require in-vivo dMRI; (4) Measure in-vivo regional myocardial contractility in patients after MI and compare BZ contractility with that in remote LV regions. If these clinical measurements also demonstrate significantly depressed BZ contractility, then procedures designed to restore a more normal LV geometry late in the remodeling process may be ineffective (as we also discovered in sheep with repaired LV aneurysm); (5) Measure in-vivo regional myocardial contractility in normal human subjects and compare these measurements with those obtained in Aim #1 and Aim #4. If these clinical measurements can be correlated to disease state and the potential effect of therapeutic intervention, then the cardiology community will be able to add a significant new methodology to its armamentarium regarding patient care protocols.

Public health relevance
Project Narrative Medical and/or surgical treatment of cardiovascular disease, especially heart failure, stands to vastly improve both the longevity and quality of life. Magnetic resonance imaging (MRI) with heart tissue tagging or cardiac tagged MRI combined with physics-based mathematical (finite element) modeling allows for non-invasive quantification of heart wall mechanical properties. If these mechanical properties can be correlated to disease state and the potential effect of therapeutic intervention, then the cardiology community will be able to add a significant new methodology to its armamentarium regarding patient care protocols. __SpecificAimsTextDelimiter__ 2. Specific Aims There are currently 5 million Americans with diagnosed heart failure (HF), and 550,000 new cases every year. Most HF cases are now the result of myocardial infarction (MI)-induced left ventricular (LV) remodeling. The lack of a well-established effective treatment has led to a continually expanding list of medical and surgical options for the palliation of HF patients. We strongly believe there are two critical barriers to rapid progress in the diagnosis and treatment of MI- induced HF in this country: (1) cardiologists cannot directly measure the forces or stresses responsible for the abnormal regional LV wall motion and/or myocardial deformation that they observe in their patients; and (2) cardiac surgeons cannot quantitatively predict the effects of a procedure or device on their patient's regional LV mechanics and global LV function. To address these barriers, we recently edited a book on computational cardiovascular mechanics (modeling and applications in HF) for clinicians as well as for biomedical and mechanical engineers. Approximately one half of our book describes in detail the state-of-the-art methodology for computing end-diastolic and end-systolic regional ventricular 3-dimensional (3D) myofiber stress and strain distributions as well as stroke volume versus end-diastolic pressure (Starling) relationships in hearts with dilated or ischemic HF before and after treatment with novel surgical procedures or devices. A non-invasive method for estimating regional myocardial contractility in-vivo would be of great value in the design and evaluation of new surgical and medical strategies to treat and/or prevent MI-induced HF. During the initial funding period, an explicit finite element (FE) model-based formal optimization of regional myocardial contractility in a sheep with LV aneurysm was performed using tagged magnetic resonance (MR) images and cardiac catheterization pressures. From the tagged MR images, 3D myocardial strains, LV volumes and geometry for the animal-specific 3D FE model of the LV were calculated, while the LV pressures provided physiological loading conditions. Active material parameters (Tmax_B and Tmax_R) in the non-infarcted myocardium adjacent to the aneurysm (borderzone) and in myocardium remote from the aneurysm were estimated by minimizing the errors between FE model-predicted and measured systolic strains and LV volumes using the successive response surface method for optimization. The optimized values of Tmax_B and Tmax_R were not overly sensitive to the passive material parameters specified. The computation time of less than 5 hours (on a single quad-core processor; 2 hours on dual quad-core processors) associated with our method for estimating regional myocardial contractility in-vivo makes it a potentially very useful clinical tool. Our method was also used to "measure" the effect of surgical ventricular restoration (SVR) for dyskinetic anteroapical MI on Tmax_B and Tmax_R in sheep. Borderzone myocardial contractility was substantially reduced compared to Tmax_R both before and after SVR. Moreover, this significant depression in Tmax_B relative to Tmax_R was confirmed in these animals by direct ex-vivo active force measurements in skinned fiber preparations. The overall goals of the proposed research are: (1) validate clinical application of our method; and (2) use our method to demonstrate a strong clinical correlation between regional myocardial contractility and disease state. Specific Aims: 1. Measure in-vivo regional myocardial contractility in 15 patients before heart transplant using our FE model- based formal optimization (described above) or Myocardial Material Property Software Tool (MMPST). We will initially use our preliminary data on regional ventricular myofiber orientation in a normal human heart. 2. Measure ex-vivo regional myocardial contractility in skinned myofibers prepared from the hearts studied in Aim 1. We will use these direct active force measurements to validate clinical application of our MMPST. 3. Using diffusion MR imaging (dMRI), measure ex-vivo regional ventricular myofiber orientation in the hearts studied in Aim 1, as well as in 10 normal human hearts and 16 human hearts with an anteroapical LV MI. If these clinically relevant measurements are not significantly different (as we showed in normal versus infarcted sheep hearts), then clinical application of our MMPST does not require in-vivo dMRI. 4. Measure in-vivo regional myocardial contractility in 16 patients after anteroapical LV MI and compare Tmax_B relative to Tmax_R. Patients with single-vessel disease (analogous to our sheep anteroapical LV MI model) will be studied at three time points separated by approximately six months. If these clinical measurements also demonstrate significantly depressed Tmax_B, then procedures designed to restore a more normal LV geometry late in the remodeling process (e.g., SVR for akinetic anteroapical MI, as in the NIH-sponsored "STICH" trial) may be ineffective. Medical and surgical strategies designed to prevent or control MI-induced LV remodeling could potentially preserve borderzone function and therefore be more effective. 5. Measure in-vivo regional myocardial contractility in 10 normal human subjects and compare these measurements with those obtained in Aims 1 and 4. If these clinical measurements can be correlated to disease state and the potential effect of therapeutic intervention, then the cardiology community can add a significant new methodology to its armamentarium regarding patient care protocols.